Three-Dimensional Spatio-Temporal Control of Lipid Nanoparticle Manufacturing for Improved Nucleic Acid Delivery

PROJECT SUMMARY
The COVID-19 pandemic has established the importance of nucleic acid-based lipid nanoparticles (LNPs)
for the future of global health. The benefits of lipid nanoparticles are multifaceted as they protect sensitive
pharmaceutical payloads from enzymatic degradation and allow for the modification of solubility, release
kinetics, and bioavailability. While chemical formulation of LNPs has been widely explored, the effects of
the formation process—specifically microfluidics processing—are not currently well-understood. This
knowledge gap presents challenges in the production of intricate nanoparticle structures, which require
specialized microfluidic systems that produce well-defined and reproducible flow regimes. In this SBIR
Phase I project, we focus on developing channel architectures to precisely control LNP structure and
properties to enhance transfection efficiency without modifying their chemical composition. Aim 1 involves
designing, simulating, and testing various 3D channel architectures to manipulate flow conditions and tailor
LNP properties. Aim 2 focuses on structural determination via SAXS and CryoTEM, and assesses the
impact of LNP structures on mRNA transfection efficiency through in vitro transfection studies. Aim 3 will
demonstrate the therapeutic- and disease-agnostic design workflow by encapsulating siRNA and pDNA.
This project aims to overcome the limitations of current LNP production methods which provide limited
control over LNP assembly processes. In the NIH I-Corps program, we will conduct extensive customer
interviews to refine our commercialization roadmap and align our product in development with target
customer needs.

Public health relevance
PROJECT NARRATIVE Current lipid nanoparticle production methods are limited to either pipette mixing or 2D microfluidic chips, the former which does not allow for any precise control over fluid interactions, and the latter being limited by fixed channel architecture with very little control over fluidic interactions beyond tuning of flow rates. We aim to accelerate the NA therapeutic development pipeline by spatiotemporal control over fluidic interfaces, resulting in higher-quality LNPs with enhanced NA delivery. In the NIH I-Corps program, we will explore the commercialization potential of our technology by learning from potential customers and refining our go-to- market strategy.